Investigating the metal-dependent function, allostery and inhibition of CRISPR-Cas9

This revision application is in response to an equipment supplement opportunity. No changes
have been made to the original project summary, narrative, or specific aims. Per NOT-GM-22-
017, please see the requested scientific justification for this equipment supplement request
within the research strategy section.

Public health relevance
This revision application is in response to an equipment supplement opportunity. No changes have been made to the original project summary, narrative, or specific aims. Per NOT-GM-22- 017, please see the requested scientific justification for this equipment supplement request within the research strategy section.